AMI FORUMS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The AMI Forum provides a forum for presentation of both the technical aspects of Core Research and Development Projects as well as the underlying biological motivation for the Collaboration and Service projects. The format is a 20-30 minute talk, accessible to a general audience, which provides an overview of the week's topic, followed by an informal discussion and questions. Typical attendance at a forum is between 30 and 60 people.